Exploring new strategy for breast cancer immunoprevention by targeting histamine receptor H1

Project Summary/Abstract
New strategies to prevent breast cancer are urgently needed because: i) breast cancer incidence rates keep
rising by 0.5% per year and about 13%, or 1 in 8, of U.S. women are going to develop invasive breast cancer in
their life time; ii) the endocrine-targeted agents for ER+ breast cancer prevention do not reduce breast cancer
mortality; iii) prevention strategy for ER- breast cancer, which has higher mortality rate, is still not available yet.
Our recent study (published on Cancer Cell 2022 Jan 10;40(1):36-52) uncovered that high levels of plasma
histamine and histamine receptor H1 (HRH1) expression in tumors (mainly on macrophages) are significantly
correlated with reduced cytotoxic immune cell infiltration and devastating T cell function in patients with breast
cancer. On the contrary, breast cancer patients who took H1-antihistamines during immunotherapy treatment
had evidently improved survival. Importantly, the association between antihistamine uptake and better clinical
outcome was only observed in patients treated with immunotherapies but not that with chemotherapies,
suggesting that H1-antihistamines may contribute to antitumor immunity. Indeed, we found that H1-antihistamine
treatment or HRH1 knockout boosted CD8+ cytotoxic T cell activities and enhanced immunotherapy responses
in several mammary tumor models. More interestingly, our latest retrospective analysis of the electronic health
record of a MDACC patient cohort with stage 0 or 1 breast cancers revealed that patients who took H1-
antihistamines had significantly reduced tumor recurrence compared to patients who did not take them. Patients
who received therapies other than surgery were excluded, suggesting that the reduced recurrence is not due to
enhanced therapeutic response. These new findings led us to hypothesize that blocking histamine-HRH1 axis
by H1-antihstamines enhances immune surveillance and intercepts breast cancer development. We propose
two Specific Aims: 1) Test the effect of H1-antihistamines on intercepting mouse mammary tumor development.
We will test i) whether H1-antihistmaines can intercept early-stage mammary tumors in mouse models that mimic
patients with early stage breast cancers (i.e., the cohort in the analysis); ii) whether H1-antihistamines will
prevent/delay basal-like breast cancer initiation/progression in a genetically engineered mouse model which
recapitulates the natural development of breast cancer; 2) Determine the impact of blocking histamine-HRH1
axis on systemic immune landscape and tumor immune microenvironment in early stage mammary tumors. We
will examine i) broad effects of H1-antihistamine on blood immune cell landscape by CyTOF; ii) impacts of H1-
antihistamines on local immunity, e.g., the spatial interactions of mammary epithelial cells and diverse immune
cell populations. Integrating above data, we will identify key changes of immune cells that are linked with
antihistamine-mediated immunoprevention. The proposed study will explore a new strategy based on our latest
findings to address the unmet challenge for breast cancer prevention. If the results are promising, our findings
could be translated into clinic trials for immunoprevention of breast cancer, especially, in women at high-risk.

Public health relevance
Project Narrative New strategies to prevent breast cancer are urgently needed because: i) breast cancer incidence rates keep rising by half percent per year and about 13%, or 1 in 8, of US women are going to develop invasive breast cancer in their life time; ii) prevention strategies for estrogen receptor-positive breast cancer do not reduce patient mortality and prevention strategy for estrogen receptor-negative breast cancer is still not available. Our proposed study aims to intercept breast cancer development by reinforcing antitumor immune response via H1-antihistamines, many of which are over-the-counter drugs to treat seasonal allergies. If the results are promising, our findings could be rapidly translated into clinic trials for immunoprevention of breast cancer, especially, in women at high-risk.